Metal-Catalyzed Nucleophilic Substitution Reactions of Alkyl Electrophiles

PROJECT SUMMARY / ABSTRACT
The discovery of powerful new methods for the synthesis of organic compounds can be enabling for
biomedical research, e.g., by providing more ready access to known families of target molecules or access for
the first time to new classes of molecules. Catalytic and enantioselective methods for carbon–carbon, carbon–
nitrogen, and carbon–oxygen formation are of particular interest, due to issues including sustainability, the
potentially divergent bioactivity of the two enantiomers of a compound, and the predominance of such bonds
in the backbone of organic molecules, respectively.
The substitution reaction of an alkyl electrophile by a nucleophile is a particularly straightforward
approach to the assembly of organic molecules. Classical pathways for substitution, such as the SN1 and the
SN2 reactions, are limited in scope with respect to both the electrophile and the nucleophile. Furthermore,
these pathways almost never provide access to highly enantioenriched products from readily available racemic
starting materials.
Through the use of transition-metal catalysis, wherein the electrophile is converted into an organic radical,
it is possible to begin to address both of the key challenges in nucleophilic substitution reactions of alkyl
electrophiles–broader scope and control of enantioselectivity. For example, chiral nickel and copper
complexes can catalyze the enantioconvergent coupling of a number of racemic secondary and tertiary alkyl
electrophiles with a variety of nucleophiles.
To date, only a small fraction of the conceivable permutations of electrophilic and nucleophilic partners for
metal-catalyzed substitution reactions of alkyl electrophiles have been explored, and still fewer such processes
have been rendered enantioselective. The goal of this research program is to address the many unsolved
challenges in this area. Efforts will focus on the development of mild and versatile methods to couple families
of electrophiles and nucleophiles that have not previously been shown to be suitable reaction partners in
aliphatic substitution reactions, including highly hindered substrates, while controlling stereoselectivity at the
same time (at up to two stereocenters), including with racemic electrophiles and nucleophiles that lack
directing groups. Success in this endeavor will substantially facilitate the synthesis of enantioenriched
molecules.
Mechanistic studies will be pursued in order to provide insight into the pathways by which the new metal-
catalyzed substitution reactions proceed. The mechanistic investigations will facilitate reaction development,
as well as enhance the community’s understanding of fundamental chemical reactivity.

Public health relevance
PROJECT NARRATIVE / RELEVANCE A wide array of scientific disciplines (including biology, biochemistry, pharmaceutical chemistry, bioinorganic chemistry, chemical biology, and organic chemistry) make use of organic compounds, especially enantiomerically enriched compounds (due to the "handedness" of the molecules of life, e.g., peptides, DNA, RNA, and carbohydrates). The development of powerful new methods for organic synthesis, particularly enantioselective synthesis, facilitates progress in biomedical research by providing access to compounds that enable the exploration of new hypotheses and the discovery of new bioactive molecules.